Strengthening Health Professional Workforce Education Programs for Improved Quality Health care in Zambia (SHEPIZ)

Despite the current global trends of substantial improvement of many health indicators, sub-
Saharan African disease burden and public health needs have continued to rise, without a
corresponding proportional and appropriate human resource response to tackle them. The
poor training response is largely compounded by the critical lack of requisite appropriate
academic structures especially those whose ethos is grounded on evidence and translational
ideas I n d e e d Sub-Saharan Africa still remains the worst hit by the HIV epidemic with an
estimated adult prevalence of 14.3% in Zambia. There is now world-wide consensus that
generation of specific knowledge bases through research coupled with appropriate training and
retraining programs targeted strategically through the health care systems and that focus on
major national priorities has great potential to reduce the associated burden and improve major
health outcomes. With this background and building on an historical array of capacity building and
training programs through the University of Zambia (UNZA) Schools of Medicine (SOM) and
Nursing (SON) including our partner institutions (Mulungushi University SOM, the Centre for
Infectious Diseases Research in Zambia (CIDRZ), Vanderbilt University, the University of
Alabama at Birmingham and the University of North Carolina), we propose to focus on
enhancement of a health services focused multilevel research capacity building program,
continued development of subspecialty trained clinicians and a multidisciplinary training quality
enhancement program. In the proposed program, we hypothesize that by strengthening the
clinical and research training capacity of our major national health professions training institution,
the University Of Zambia School Of Medicine, the national health workforce competences will be
enhanced with resultant improved health outcomes. We aim to achieve this by creating both short
and mediam long term dynamic health professions clinical research training programs. It is
envisioned that by end of this grant program period a number of outputs will have been realized
including 1) established clinical and research training programs for the enhancement of health
Professions workforce in the country with regard to HIV and none communicable Diseases
(NCDs) care, 2) a critical mass of health professional specialists (medical and nursing sciences)
providing health professional workforce leadership, and 3) developed e-based dynamic and
innovative courses and e-learning networks for continuous professional development (CPD)
country-wide.

Public health relevance
The proposed SHEPIZ project is an innovative medical education program focused on enhancement of health services, multilevel research capacity building and continued development of subspecialty trained clinicians in Zambia